AGE-RELATED CHANGES IN PROTEIN AND ENERGY INTERACTIONS

To examine if, during aging, the interactions between energy and protein metabolism change in ways that may compromise the individual's ability to respond "successfully" to physiologic and pathologic stress.